SEQUENCING BY HYBRIDIZATION WITH UNLABELED DNA

This research project is aimed at developing a novel DNA sequencing, mapping, or diagnostic technique that requires no DNA labeling. The proposed innovative technique would even allow genomic DNA to be used for diagnostics, thus significantly reducing preparation cost (no polymerase chain reaction would be necessary). During Phase l we experimentally evaluated the most promising detection techniques and demonstrated the feasibility of the procedure. In Phase Il we plan to systematically determine the best parameters for probe immobilization and hybridization and determine the sensitivity of these procedures to variations in the parameters. We will also develop a less expensive prototype instrument that could be purchased by major facilities. Because of the potential cost effectiveness, accuracy and speed of this innovative technique, commercial benefits could be tremendous. PROPOSED COMMERCIAL APPLICATIONS: Commercialization could begin by supplying analytical services to researchers at national and private laboratories. Instrument sales would be first targeted to major research and clinical laboratories, but would grow to areas outside the biomedical field due to the wide applicability of the technique.